Oxytocin projections mediate social and drug reward

Project Summary
Substance use disorder (SUD) is prevalent in the US with over 10% of adults fitting the criteria for diagnosis.
Unfortunately, SUD treatments are often unsuccessful, with up to 75% of patients experiencing relapse. SUD is
associated with problematic reward processing, leading to drug use at the expense of natural rewards and
despite negative consequences. Addiction recovery programs often require drug abstinence while reinforcing
engagement with natural rewards such as socialization. Research suggests that oxytocin administration could
help with this process and improve treatment outcomes for SUD. Although the therapeutic potential of oxytocin
is already being investigated in clinical trials with encouraging outcomes, the effects of oxytocin on reward-
related neural circuits are not understood.
Most studies point to oxytocin decreasing the reinforcing effects of drugs but increasing the salience of social
stimuli. The detection of rewarding stimuli is regulated in part by the mesolimbic dopamine system, with
dopaminergic cell bodies in the ventral tegmental area (VTA) that project to the nucleus accumbens (NAc).
Emerging evidence suggests that different circuits facilitate drug versus social reward, with drug reward
depending on phasic (fast bursts) dopamine release and social reward on tonic (slow, steady) dopamine
release in the NAc. Oxytocin’s therapeutic effects for addiction may be a result of oxytocin shifting dopamine
release patterns from phasic to tonic, thus rebalancing the pathways facilitating drug and social reward. The
current proposal will assess the role of oxytocin projections and oxytocin receptors located in reward-related
brain regions on preference for drug vs social reward and phasic vs tonic dopamine release.
The proposed study will be the first to systematically investigate the neural pathways and receptor sites utilized
by oxytocin to mediate reward processing. The proposed study incorporates contemporary techniques for
manipulating neural circuits (DREADD and CRISPR/Cas9 technologies) and inventive twists on conditioned
place preference testing and in vivo dopamine quantification. Clarifying the mechanisms by which oxytocin
mediates drug and social reward is crucial for harnessing the full therapeutical potential of oxytocin for SUD.

Public health relevance
Project Narrative The neuropeptide oxytocin is being investigated as a much-needed treatment for substance use disorder; however, the neural mechanisms of oxytocin are not understood. In the proposed study, we will examine the oxytocin neural pathways that mediate preference for social vs drug rewards and specific aspects of mesolimbic dopamine release. Understanding and capitalizing on oxytocin’s ability to decrease the reinforcing effects of drugs while increasing the salience of social rewards is crucial to its effective therapeutic use.